Pathogenicity and pathophysiology assessments of sarcomere gene variants identified in the clinic

PROJECT SUMMARY/ABSTRACT
A variant of unknown/uncertain significance (VUS) is a change in an individual’s genetic sequence that has an
unknown effect on the individual’s health. It is estimated that several hundred thousand individuals in the US
carry VUSs in the gene encoding cardiac troponin T, TNNT2, an essential component of the thin filament of the
sarcomere—the basic contractile unit of the cardiomyocyte. Because pathogenic TNNT2 variants cause at least
two forms of heart failure with distinct prognoses and treatment responses, this VUS pathogenicity knowledge
gap has tremendous consequences in the clinic. Previous functional studies of a small number of pathogenic
TNNT2 variants have supported a myofilament tension-based pathogenesis model whereby TNNT2 variants that
increase myofilament tension through increasing thin filament calcium (Ca2+) sensitivity cause hypertrophic
cardiomyopathy (HCM), a disorder with impaired cardiac relaxation that is the most common cause of sudden
cardiac death in young athletes. In contrast, TNNT2 variants that decrease myofilament tension through
decreasing Ca2+ sensitivity cause dilated cardiomyopathy (DCM), a disorder with impaired cardiac contraction
that has a mortality rate of 50% at five years due to progressive heart failure. The central goal of our proposal
is to reclassify the pathogenicity of all TNNT2 VUSs and identify their pathophysiology, which would more
precisely inform heart failure risk type and treatment responses in the clinic. In Aim 1, we will study the 251
TNNT2 VUSs from ClinVar, an extensive database of genomic variation in humans linked to disease status. We
will use a recently developed experimental platform designed to comprehensively interrogate the function of
TNNT2 variants within the context of human cardiomyocytes (iPS-CMs) differentiated from induced pluripotent
stem (iPS) cells and validated using 3-dimensional cardiac microtissue assays exhibiting advanced cellular
maturation, multicellular architecture, and biophysical inputs. In Aim 2, we will perform a deep mutational scan
of all possible missense TNNT2 variants using iPS-CMs expressing a transcriptional reporter assay, flow
cytometry, and next-generation sequencing that we previously validated to predict the pathogenicity and
pathophysiology of gold-standard TNNT2 variants with >91% accuracy. Finally, in Aim 3, we will interrogate the
pathogenicity in vivo of two VUSs that function like pathogenic variants in vitro, using C57BL6/J inbred mice and
myotropic adeno-associated viruses (MyoAAVs) delivering physiological troponin T levels. Our study will provide
essential pathogenicity and pathophysiology determinations for VUSs in an important heart failure gene,
establish new insights into troponin T functions, and provide a blueprint to resolve VUSs in other heart failure
genes.

Public health relevance
PROJECT NARRATIVE Inherited pathogenic variants in the cardiac troponin T gene (TNNT2) cause two forms of heart failure with distinct pathophysiology and treatments, yet most TNNT2 variants identified in the clinic are variants of unknown functional and clinical significance (‘VUSs’) that paralyze clinical decision making and treatment choices. Our study will comprehensively test the functionality of all TNNT2 variants in the human population using human cells, biomimetic cardiac microtissues, and humanized mouse models. This research will improve our understanding of heart failure pathogenesis and the precision of heart failure treatments.